Building Interdisciplinary Research Careers in Women's H

DESCRIPTION (provided by applicant): The long-term goals of the Duke/North Carolina Central University (NCCU) "Building Interdisciplinary Research Careers in Women's Health" (BIRCHW) program are (1) to contribute to improvement in women's health by providing training and experience in research methodology to new investigators interested in addressing important questions, (2) to foster innovative approaches to these questions by encouraging investigators to utilize the wide range of intellectual capital available through interdisciplinary training and collaboration, (3) to build the capacity of Duke and NCCU to provide leadership in women's health research, and (4) to serve as a model for broad-based interdisciplinary research training and collaboration for both universities. The program will reach these objectives by achieving the following specific aims: (1) providing didactic and practical training in the conduct of research in women's health for junior faculty across a broad spectrum of disciplines, focusing on 4 broad areas: Clinical Trials and Outcomes, Decision Making, Health Disparities, and Basic and Translational Research; (2) building upon existing interdisciplinary faculty relationships to foster productive and innovative collaborations; (3) creating new interdisciplinary research relationships between Duke and NCCU faculty; (4) providing additional mechanisms for the ongoing exchange of ideas, methods, and insights among the community of researchers at Duke interested in women's health; (5) providing a mechanism for recruitment and career development of junior faculty committed to the long-term goals of the program; and (6) enhancing overall research productivity of faculty by encouraging and facilitating interaction between clinician and non-clinician researchers. Trainees in the program will have a minimum of 2 years of mentored research training, including weekly seminars on research methods and career development topics, experience in peer review and grant writing, and completion of at least one project working in conjunction with a senior faculty research mentor. Trainees will be expected to complete and submit at least one application for independent research training by the end of their time in the program.